IGF::OT::IGF ARTIFICIAL INTELLIGENCE IN MEDICINE INC: HHSN261201500033I- TASK ORDER 2; POP 9/26/2016-9/25/2017

The purpose of this acquisition is to 1) maintain and update the existing Surveillance Epidemiology and End Results (SEER) ePath network; 2) expand the SEER network to additional pathology laboratories; 3) expand electronic data capture to include electronic reports from diagnostic imaging, and 4) install cancer data forwarding module in previously installed ePath laboratories